Experiences of Bowel Self-Management in Adults with Spina Bifida: A Qualitative Descriptive Study

Project Summary/ Abstract
Spina bifida (SB) is the most common congenital neural tube defect in the US, occurring in more than 1,400
births each year and resulting in lifelong disability. A highly disabling aspect of spina bifida is neurogenic bowel
dysfunction, which requires lifelong self-management (SM) independently or together with a caregiver. Bowel
SM in adults with SB is incredibly complex, making it difficult to achieve sustained fecal continence. There is
little support available for this population attempting bowel SM and this area is remarkably under researched
even though unmanaged bowel dysfunction leads to poor outcomes such as fecal incontinence, constipation,
urinary incontinence, urinary tract infections, shunt malfunctions, skin breakdown, hemorrhoids, anal fissures,
loss of social and work opportunities, and feelings of shame, helplessness, and social isolation. Without proper
bowel SM and support from appropriate clinicians, neurogenic bowel dysfunction has a significant and
devastating impact on quality of life. There is a critical need to address bowel SM in adults with SB, as this area
of SM is one of the most important challenges associated with a spina bifida diagnosis. This is especially true
for the Hispanic population and the underinsured who are at increased risk for poor bowel SM-related
outcomes. The purpose of this study is to describe the experiences of adults with SB engaging in bowel SM
from their perspectives. Thus, the specific aim is to describe the bowel SM experiences of adults with SB and
the research questions are: 1) What are the challenges adults with SB face when engaging in bowel SM? 2)
What bowel SM strategies do adults with SB use? 3) What are the bowel SM experiences of underinsured and
Hispanic adults with SB? A qualitative descriptive design using a sample of 20-30 English and Spanish
speaking adults with SB will be recruited through the
Riley Adult Spina Bifida Clinic at Indiana University Health
Riley Hospital for Children
, the Spina Bifida Association, and the Bowel Management for Spina Bifida Facebook
group using both paper and digital fliers. All materials will be available in both English and Spanish. Interested
participants will be directed to an online link to learn more about the study, provide consent electronically, and
fill out a demographic survey. I will contact participants to set up a virtual interview with an interpreter present
for Spanish speaking participants. Interviews will be recorded, transcribed, and analyzed using Sandelowski’s
method for data preparation and analysis. Results of this study will guide future research, including the
development and testing of equitable patient-centered interventions to improve bowel SM and quality of life in
adults with SB. I have worked closely with her sponsors to develop a rigorous training plan that will provide a
solid foundation for her dissertation and long-term professional development as a nurse scientist. Her training
goals are to: 1) develop in-depth knowledge of bowel SM in adults with SB; 2) gain expertise in qualitative
descriptive methods; 3) gain expertise in grant writing; 4) present research findings and engage in professional
development and networking activities; and 5) submit manuscripts for publication.

Public health relevance
Project Narrative Neurogenic bowel dysfunction is one of the most burdensome and disabling issues for adults with spina bifida (SB), especially in vulnerable populations who are disproportionately affected by poor bowel-related outcomes, yet little is known about the experience of engaging in bowel self-management (SM) from the perspective of adults with SB. The purpose of this study is to describe the bowel SM experiences of adults with SB with a focus on bowel SM challenges, strategies, and the experiences of two vulnerable populations (Hispanic population and underinsured population). This work is aligned with patient-centered priorities identified by the Spina Bifida Association and is the first step in developing equitable and effective patient-centered interventions to improve bowel SM and overall quality of life in adults with SB.